Role of Renal Lymphatics in Blood Pressure Regulation

PROJECT SUMMARY/ABSTRACT
Almost 1 in 2 Americans will develop hypertension (HTN) while half of these people will develop salt-sensitive
hypertension (SSHTN). Precision medicine and novel therapies that combat the cardiovascular and renal
complications of HTN and SSHTN are critically needed. The long-term goal is to develop a safe and effective
therapeutic that targets renal lymphatic vessels to reduce renal injury and HTN. The objectives of this
application are to determine the role that renal lymphatics play in renal immune cell accumulation and
inflammation in HTN and whether increasing renal lymphatics can reduce renal injury and blood pressure. HTN
is associated with activated immune cell infiltration into the kidney leading to interstitial inflammation and renal
injury. The resolution of inflammation involves an increase in lymphatic vessels to clear the interstitial immune
cells and fluid, but inadequate lymphatic responses result in persistent inflammation and tissue injury.
Accumulation of pro-inflammatory immune cells in the kidney plays a key role in HTN; however, the role of
renal lymphatics in HTN is unknown. The central hypotheses are that (1) HTN stimuli (salt, angiotensin II,
asymmetric dimethylarginine) cause immune cell activation, infiltration, and inflammation in the kidney which
contributes to a compensatory increase in renal lymphatics, (2) HTN stimuli in the renal interstitial fluid directly
affects renal lymphatic cell biology and function, and (3) that further augmenting renal lymphatics is sufficient to
attenuate renal injury and HTN. Recent publications and preliminary data support these hypotheses. The
hypotheses will be tested by 3 specific aims: (Aim 1) Determine how renal lymphatics are affected in HTN and
the mechanisms involved; (Aim 2) Determine how HTN stimuli directly impact lymphatic cell biology and
function; and (Aim 3) Determine how inducing renal lymphangiogenesis affects renal inflammation and HTN.
Various combinations of pharmacologic and genetic perturbations of renal lymphatics in mice as well as the
examination of molecular mechanisms in lymphatic cells and isolated vessels will be used. The study will also
examine renal lymphatics in humans with and without HTN as well as develop and test a kidney-specific
nanoparticle that induces lymphangiogenesis. The innovation of the proposed research lies in the elucidation
of the role that lymphatic vessels in the kidney play in renal inflammation and blood pressure regulation and
how augmenting renal lymphatics can reduce kidney injury and HTN. Technical innovation includes the
development of unique transgenic mice and a kidney-specific lymphangiogenic nanoparticle. This contribution
will be significant because the results may provide clinicians with a new strategy to improve kidney health and
lower blood pressure in some of the ~148 million adults in the US with HTN.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because millions of people, now ~1 in 2 people in the US, have high blood pressure, which negatively affects their health and places them at a high risk for heart attacks, strokes, and kidney problems. Our goals are to understand how lymphatic vessels in the kidney affect blood pressure regulation and whether we can increase kidney lymphatic vessels to decrease blood pressure. These goals are relevant to the mission of NHLBI because being able to specifically reduce high blood pressure will improve the health and quality of life for some of the ~148 million Americans as well as develop, diversify, and sustain a scientific workforce.